Structure, Function, and Dynamics of Non-Canonical Stress Granules

SUMMARY/ABSTRACT
Stress granules (SGs) are dynamic, membrane-less cytoplasmic condensates of proteins and mRNAs
that form in response to stressful stimuli. SGs have been linked to a broad variety of cellular processes and
disease states and thus are of broad biological importance. However, much remains unknown about the
structure and function of SGs. SG composition is specific to stress type, cell type, and disease state. So called
“canonical” (Type I) SGs form downstream of integrated stress response activation, and are thought to be anti-
apoptotic, such as those caused by acute arsenite exposure and heat shock. Other stress conditions, such as
ultraviolet (UV) radiation, cause the formation of “non-canonical” SGs (Type II) with altered composition,
unique kinetics, and unknown function. Many studies have thoroughly documented the composition and
dynamics of canonical SGs caused by arsenite and heat. However, similar studies of non-canonical subtypes,
like UV SGs, have not been performed. Our preliminary data concur with reports that UV SGs are essentially
lacking in poly(A)+ RNA. We further observe for the first time that UV SGs lack the apoptotic scaffolding
protein RACK1. Our results suggest that UV SGs, unlike canonical SGs, may be pro-apoptotic. Several studies
have suggested that RNA-RNA and RNA-protein interactions contribute importantly to the liquid-liquid phase
separation (LLPS) required for SG formation. However, if it is true that UV SGs do not contain a significant
amount of RNA, this creates a paradox surrounding the role of RNA in SG formation. Our overarching
hypothesis is that UV SGs represent a sort of “minimal SG” in that they appear to contain fewer proteins and
RNA components than canonical SGs. We reason that UV SGs can be used as a model to understand the
protein-protein interactions that drive SG formation. The goal of the proposed research is to define the
composition, understand the mechanism of formation, and determine the function with respect to apoptosis, of
UV SGs. To achieve these goals, we propose the following specific aims: Aim 1: Characterize the components
of non-canonical UV SGs. We will test the working hypothesis that UV SGs represent a “minimal SG” and
contain fewer proteins and RNAs than canonical arsenite-induced SGs, utilizing a SG purification strategy in
tandem with live and fixed cell imaging. Aim 2: Elucidate the relationship between non-canonical UV SGs and
apoptosis. Our working hypothesis is that phase separated UV SGs do not sequester apoptotic factors and
therefore confer no benefit to the cell with respect to apoptosis. The studies proposed here are significant
because they address several key unanswered questions in SG biology, including the composition of non-
canonical SGs and the dynamic relationship between SG subtypes and apoptosis. Our approach is innovative
in that we are utilizing SG subtypes as a mechanism to elucidate the role of RNA phase separation and
protein-protein interactions within SGs in a way that has not, to our knowledge, been proposed.

Public health relevance
PROJECT NARRATIVE RNA granules are aggregates of RNAs and proteins that form inside many cells and are essential for numerous biological processes. This proposal will help elucidate the functions of a particular type of RNA granules known as stress granules, which form in response to environmental stress and are associated with many disease states. Understanding the function of stress granules will help us understand how aberrant stress granule formation leads to disease, and how we can better interrupt the process to treat various diseases.